Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
The role of the Biostatistics and Bioinformatics Core is to support the investigators of the SPORE in Bladder
Cancer in their research efforts, including laboratory experiments, molecular studies and analysis of clinical
trial and correlative data. Prior to the initiation of all studies, Core staff will consult with SPORE investigators to
discuss the underlying scientific premise and translational goals of the project, to help the investigators select
the most efficient and robust analytical methods, and to estimate sample sizes to ensure adequate power to
address study objectives. In laboratory experiments, Core members will assist in the formulation of the
experimental design and in the analysis and interpretation of the data at the conclusion of the study. For
molecular studies using human tissues, Core members will closely interface with the members of the
Biospecimen Repository Core, and will have primary responsibility for merging molecular and clinical data, and
for performing appropriate statistical and bioinformatics analyses. The members of the Biostatistics and
Bioinformatics Core will also work with SPORE investigators to format data for publication and assist with
deposition of genomic data into public repositories to facilitate validation of results by external investigators
using their own analytical methods. For clinical studies, they will work with SPORE investigators to help set up
effective systems to collect and track all required data. As the RP studies proceed, Core staff will review
project databases and monitor the quantity and quality of data collected, and they will suggest modifications to
the design and analysis plans as appropriate. When studies are finished, the Core will conduct correct and
efficient data analyses. They will also assist investigators with the preparation of any necessary graphs and
tables, the interpretation of results, the preparation of presentations and manuscripts, and will consult on the
design of subsequent research. If current statistical methodology does not adequately address a research
question, alternative methodologies will be developed. We believe that this experienced and collaborative Core
is well configured to provide the SPORE in Bladder Cancer with a high level of statistical and bioinformatics
leadership and support that will enhance the efficiency, quality, and quantitative rigor of its science.

Public health relevance
PROJECT NARRATIVE The Biostatistics and Bioinformatics Core will provide direct support for study design and timely execution of data analysis for all research projects and developmental projects in the MSK SPORE in Bladder Cancer.